A novel link between calcineurin, amino acid permease, and protein kinase A in virulence in Mucor

Summary
Mucormycosis, which is caused by Mucorales fungi, is a life-threatening condition that poses a challenge to
immunocompromised patients. As the susceptible cohort increases, the incidence of mucormycosis is rising.
Mucormycosis has an unacceptably high mortality rate of more than 90% in disseminated infections and 50%
overall in all cases. To make matters even worse, a number of reports concern the high level of intrinsic
antifungal resistance in Mucorales. Therefore, there is an urgent need for the development of new antifungals
to overcome lethal fungal infections. One very well-known virulence factor in fungi is calcineurin, a
serine/threonine phosphatase, which is required for the invasive hyphal growth in the model Mucorales Mucor
circinelloides (denote Mucor). This attribute of the phosphatase makes a highly attractive target of antifungal
drugs. However, calcineurin is highly conserved in fungi and humans, which in practical terms has translated
into our inability (despite major efforts by multiple groups of investigators over the years) to directly use
pharmacological inhibition of calcineurin as an antifungal strategy. Fungal specific downstream of calcineurin
that is absent in mammalian cells will potentially solve the conundrum and open a brand-new avenue for the
development of novel antifungal drugs. During preliminary studies, we discovered that, in Mucor, 1) mutations
in an amino acid permease gene results in resistance to calcineurin inhibitors such as FK506, 2) the resistance
is caused by an elevated activity of protein kinase A (PKA), and 3) the amino acid permease positively
regulates the activity of PKA. These observations have never been reported in any fungal systems and will
lead a completely different direction to study calcineurin as a target for drugs. Based on this observation, our
hypothesis in this proposal is that the resistance mechanism to calcineurin inhibitors via the genetic link
between calcineurin, amino acid permease, and PKA is conserved in pan-fungal systems. Three specific aims
include identification of a key transcription factor(s) regulated by calcineurin in the regulation of the amino acid
permease BycA expression (Aim 1), elucidation of the roles of BycA in virulence (Aim 2), and demonstration of
the link between BycA and PKA (Aim 3).

Public health relevance
Public relevance narrative- This proposal will elucidate a novel link between calcineurin, an amino acid permease, and protein kinase A in pathogenesis in Mucor. Calcineurin is a key virulence factor in pathogenic fungi and, therefore, has long been considered as a promising target for antifungal drug development. This study will provide a paradigm-shift idea to target calcineurin for efficient treatment of mucormycosis in human.